Mentoring patient-oriented research on the health consequences of polydrug use

ABSTRACT
Dr. Elise Riley is a Professor in the Division of HIV, Infectious Diseases and Global Medicine at
the University of California, San Francisco. Trained as an epidemiologist, she has mentored 57
postdoctoral fellows and early-career faculty throughout her career while simultaneously leading
research focused on the health consequences of HIV and drug use. She is currently funded by
NIDA to conduct a study regarding the influences of polydrug use, viral load and inflammation
on small vessel disease in people living with HIV. Here she proposes an expansion of the
parent study to include measures of tryptophan catabolism, which will provide a better
understanding of cerebrovascular dysfunction through the consideration of multiple
physiological pathways. Within this expanded investigation, Dr. Riley will continue growing and
improving the content of her individual-level mentoring program. In parallel, she will partner with
the UCSF Center for AIDS Research (CFAR) to create a new virtual mentoring module within
the existing CFAR mentoring program. In combination, the proposed activities will provide
multiple opportunities for training in patient-oriented research and career development for early
career investigators.

Public health relevance
PUBLIC HEALTH RELEVANCE Stroke and premature death are disproportionately high in people living with HIV. A current study led by Dr. Riley considers how combinations of drugs and inflammation exacerbate conditions that precede stroke. The objective of the current proposal is to expand the existing research to consider tryptophan catabolism as an additional physiological pathway of stroke- related conditions, and augment mentoring activities alongside the research. This comprehensive program will provide an effective training environment for mentees conducting patient-oriented research. At the same time, it will facilitate the development of clinical tools for risk assessment to reduce stroke in people living with HIV.